Quantifying phenotypic adaptation of biological systems in dynamic environments

PROJECT SUMMARY/ABSTRACT
Despite recent experimental advances in high-dimensional time-course data generation and accompanying
inferential statistical approaches, we still lack the ability to reliably estimate the time-dynamical adaptation
mechanisms that biological systems utilize to navigate varying environments. The major obstacle preventing a
mechanistic understanding of dynamic adaptation is an absence of hybrid theory- and data-driven models that
integrate biological mechanisms of adaptation with their effects on state transitions and associated fitness in a
variable environment. By leveraging my prior expertise in modeling stochastic biological processes and building
upon our recent mathematical characterization of optimized adaptation strategies, this research project will
develop a comprehensive computational framework to address this need. In the next five to ten years, we will
address three main research goals: 1) design a mathematical framework for tracking the effects of variable, time-
dependent adaptation, 2) validate computational models accounting for dynamic adaptability using time-course
gene expression and sequencing data, and; 3) apply, in close experimental and clinical collaboration, the
modeling framework to understand disease-specific adaptability through antigen signatures that evolve in the
presence of an adaptive T cell immune repertoire. Since dynamic adaptation is fundamental to many biological
processes with therapeutic implications for treatment resistance, this modeling framework will be useful for
predicting the time-dependent effects of prior environmental histories on the phenotypic outcome of adaptive
systems. Such predictions will also enable additional in silico evaluation of the effects of intervention on disease
outcome. The proposed research will improve our understanding of the general principals governing dynamic
adaptation in biological systems and provide a more comprehensive characterization of the role of antigenic
adaptability in the setting of a time-varying immune environment.

Public health relevance
PROJECT NARRATIVE This project will create a computational framework capable of describing and estimating the time-dynamic adaptation of biological systems that occur in variable environments using imputed data sampled over multiple time points. We will apply our developed model to study the adaptation strategies utilized by SARS-CoV-2 and leukemia to evade targeting by the immune system. This project will contribute to our fundamental knowledge on the adaptation strategies that are utilized by biological systems in navigating dynamical environments, which is directly useful for better understanding treatment failure in many medical contexts such as infectious diseases and cancer.